METABOLIC REGULATION OF PLASMA LIPOPROTEIN LIPASE IN MAN

The study will evaluate how plasma lipase activity, measurable without heparin injection, responds to physiologic stimuli and how response is altered in disease states, i.E. Diabetes mellitus, hypertriglyceridemia.